OPTImal vasoPRESsor in persistent pulmonary hypertension of the newborn (OPTIPRES)

PROJECT SUMMARY
Perinatal asphyxia is the leading cause of mortality in term newborns globally. Persistent pulmonary
hypertension of the newborn (PPHN) is reported in about a quarter of the neonates with perinatal asphyxia is
often secondary to meconium aspiration syndrome (MAS) and is a significant contributor to mortality. Majority
of critically ill newborn infants with asphyxia and PPHN undergo therapeutic hypothermia and have systemic
hypotension requiring vasopressors. However, commonly used vasopressors in newborns have variable
effects on systemic and pulmonary vascular beds. Non-selective increase vascular tone in both systemic and
pulmonary circulations in response to vasopressor agents may exacerbate PPHN. However, persistently low
systemic blood pressure can lead to prolongation of a right-to-left shunt and worsen hypoxemia. The ideal
vasopressor that is selective to systemic circulation and increases the ratio of systemic to pulmonary vascular
resistance (SVR/PVR ratio) and enhances vital organ perfusion is not known. Additionally, the vascular and
cellular mechanisms of vasopressor-induced changes in systemic and pulmonary circulations, in the setting of
increased pulmonary vasoconstriction from PPHN and exposure to supplemental oxygen therapy remain
unknown.
In this K08, I will perform a randomized trial comparing the effect of use of dopamine, norepinephrine,
epinephrine and vasopressin on SVR/PVR ratio, ventricular function, and cardiac output in a perinatal term ovine
model of meconium aspiration, PPHN, therapeutic hypothermia and systemic hypotension. I hypothesize that
use of norepinephrine and vasopressin will selectively increase SVR resulting in higher SVR/PVR ratio compared
to dopamine and epinephrine that will non-selectively increase SVR and PVR without affecting the SVR/PVR
ratio. Furthermore, I will perform in-vitro vascular reactivity testing with the vasopressor agents on systemic and
pulmonary arteries from control and PPHN lambs ventilated with 30% and 100% O2 respectively and investigate
vasopressor receptor expression. My training goals include acquiring hands-on experience in performing bedside
targeted neonatal echocardiography, attaining practical experience in testing in-vitro vascular reactivity in
response to vasopressors, interpreting vasopressor receptor expression in PPHN and hyperoxia, and enhancing
my knowledge of biostatistics while developing professional and leadership skills necessary for executing
development, that are in line with my research aims in this K08. These four key training goals along with
preliminary data generated from this K08 will prepare me in applying for an R01 to investigate optimal blood
pressure management in PPHN including dose-escalation of vasopressors.

Public health relevance
PROJECT NARRATIVE Infants with persistent pulmonary hypertension and systemic hypotension are at high risk of mortality. The ideal vasopressor that will selectively constrict systemic arteries and increase the ratio of systemic to pulmonary vascular resistance and cardiac output is unknown. This application seeks to fill this knowledge gap by a randomized trial comparing the commonly used vasopressors in newborns in an ovine model of meconium aspiration, persistent pulmonary hypertension of the newborn and systemic hypotension.